NRSA Training Core

The importance of the CTSA TL1 program is underscored by a fundamental realization that the future of
science is dependent, to a large extent, on the quality of training today. This is especially true within the field of
clinical translational science (CTS) where, prior to the advent of the CTSA TL1 program, formal curricula were
few and far between. This latter point was certainly true of the environment at UCI. The founding of the ICTS
KL2 and TL1 programs has transformed the NRSA training and mentored career development environment at
UCI. Our goal in this renewal is to enhance the quality of our TL1 program by pursuing the following specific
aims. Specific Aim 1: Champion NRSA training by providing an integrated TL1 program that consists of
outstanding leadership and oversight at all levels. Our administrative structure is highlighted by a team that
consists of program directors, administrative team, Executive Committee, and External Advisory Committee.
Collectively, they are guided by a strong survey, evaluation, and tracking team, and implementation of Quality
by Design principles. Additionally, we have begun discussions with our Provost that will result in a campus-
wide strategic plan focused on NRSA training and mentored career development. Specific Aim 2: Provide a
flexible and innovative curriculum that emphasizes both core and advanced competencies in CTS. We
will continue to offer a strong complement of workshops, journal clubs, formal courses, and certificate
programs focused on core and advanced competencies in CTS. In this context, we will refine our Focused
Flexible Accelerated Studies (FFASt) course on CTS core values and add new FFASt modules focused on: 1)
the development of collaboration plans (Team Science curriculum), 2) community engagement studios
(Community Engagement curriculum), and 3) network medicine (Big Data and Informatics curriculum).
Specific Aim 3: Maximize access to the NRSA training program. One of our main priorities is maximizing
opportunities for our trainees to pursue scientific discovery and the promotion of health. We will 1) expand our
program by providing institutional support for two additional trainees, 2) continue our Affiliated Scholars
Advancement Program, which significantly expands training opportunities for unfunded CTS trainees, and 3)
continue to promote diversity. Specific Aim 4: Implement and integrate local, regional, and national
strategies to transform NRSA training. Locally, we created a campus-wide “KT Training Council” whose
goal is to promote training and career development (e.g., K and T NIH mechanisms). This council interacts with
senior leadership at all levels, including ongoing and evolving discussions with our Provost. Regionally, ICTS
will continue to chair and administer the Western CTSA Education Consortium, which includes the CTSAs in
California, Oregon, and New Mexico. This consortium is focused on all aspects of the CTSA’s KL2 and TL1
programs. Nationally we will continue to participate in key programs like the Domain Task Force on workforce
development and the Common Metrics Turn the Curve program.